Quantitative Analysis Research Core (QuARC)

Program Director/Principal Investigator (Last, First, Middle): Stergiou, Nick
Project Summary
The Quantitative Analysis Research Core (QuARC) emerges as a strategic evolution of the Nonlinear Analysis
Core (NONAN), expanding its scope to provide comprehensive quantitative methods necessary for innovative
research in human movement variability to treat and prevent motor-related disorders. This transition, driven by
MOVCENTR user feedback and our commitment to adaptability, broadens our analytical capabilities beyond
nonlinear time series analysis to encompass a wider range of quantitative methods. QuARC will be a unique and
nimble resource that supports MOVCENTR investigators through expertise across a broad spectrum of
quantitative approaches, including advanced statistical modeling and machine learning, all while retaining
NONAN's core competencies. The aims of QuARC are: 1) Expand and maintain a comprehensive suite of
quantitative analysis resources to examine human movement variability data, supporting interdisciplinary studies
conducted by academic and industrial researchers with the goal of treating and preventing motor-related
disorders; 2) Serve as an advanced training and mentoring center for all MOVCENTR investigators, including
students and postdoctoral fellows, in applying diverse quantitative methods to human movement data; and 3)
Provide expertise for quantitative analysis of human movement data, establishing strong collaborations with
researchers at the University of Nebraska at Omaha, throughout Nebraska, the Great Plains IDEA-CTR network,
and beyond, while expanding partnerships with healthcare, sports technology, and biotechnology firms. This
diversification will increase the QuARC’s impact, visibility, and sustainability, positioning MOVCENTR at the
forefront of quantitative analysis in human movement variability research.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page 1 Continuation Format Page